Integrated Health Sciences Facility Core

Abstract: Research in the Rochester Environmental Health Sciences Center (EHSC) spans the translational spectrum that includes basic discovery (using experimental and epidemiologic approaches), informing solutions (interventions, risk assessment and management), and delineating health impacts of environmental exposures and policy changes. Since its inception in 2007, the Integrated Health Sciences Facility Core (IHSFC) of the EHSC has maintained a sustained track record of facilitating research across the translational research spectrum. The IHSFC structure is poised to strategically advance translational research on exposures and interactions of environmental factors that affect health and disease across the lifespan. Its core services provide expertise in contemporary research models, exposure and epigenetic analysis, and human subjects research. The IHSFC has four facilities with broad translational capabilities: Behavioral Sciences Facility, Inhalation Exposure Facility, Epigenetics Facility, and Elemental Analysis Facility. Integrating these services and technologies within the IHSFC promotes efficiency and access for all Center members. The IHSFC is led by a dynamic team of Co- Directors who are internationally recognized experts in their respective fields. The IHSFC Co-Directors use their substantial administrative expertise to coordinate the Core and integrate its activities with the other Center components and with other resources at the University. They also provide expertise in translational environmental health sciences research, including human subjects research. The four IHSFC facilities are directed by highly collaborative faculty members with successful track records of conducting multidisciplinary research. The IHSFC engages with Center researchers, others at the University, and community partners to promote collaborations and advance the mission of the Center. The IHSFC helps Center members identify needs and connect with services to enhance their research program. Also, IHSFC Co-Directors and Facility leaders are integrally involved with the University of Rochester Clinical & Translational Sciences Institute (CTSI), enabling them to foster collaborations and cross-utilization of CTSI resources to enhance EHSC research. Moreover, by working closely with the Community Engagement Core, we identify opportunities to support research that responds to community needs. The specific objectives of the IHSFC are to: (1) Provide a portal of entry to facilitate and integrate research by members of the EHSC across the translational research spectrum; (2) Support unique research opportunities provided by the Behavioral Sciences, Inhalation Exposure, Epigenetics, and Elemental Analysis Facilities for researchers within and outside the Center; (3) Provide individualized assistance in clinical and Human Subjects research; (4) Develop new technologies to advance Center research; and (5) Work with the Community Engagement Core to enhance research partnerships with community stakeholders. Regular feedback from Center members and from our Internal and External Advisory Committees guides continuous improvements in meeting the needs of Center members and our partners.